MULTICENTER STUDY OF HYDROXYUREA IN SICKLE CELL ANEMIA

Patients with Sickle Cell Anemia will be treated with increasing doses of Hydroxyurea to increases in fetal hemoglobin production as functions of Hydroxyurea dose, renal clearance of hydroxyurea and pre-treating hematologic characteristics. Uncontrolled clinical observations will be made.